THE EFFECTS OF HYPOOSMOTIC SOLUTIONS ON CULTURED CEREBROVASCULAR ENDOTHELIUM

The cerebral microvessels, the active constituents of blood-brain barrier (BBB) possess many complex properties which are engaged in ensuring an optimal hemostatically controlled environment for the brain. Since the capillary endothelial ability to regulate its volume should be prerequisite for maintaining the function of the barrier, we investigated the response of intrinsic endothelial mechanisms to hypotonicity. The exposure of viable endothelium to a medium of half normal osmolality resulted in immediate cellular swelling, reduction in transmembraneous potential and intracellular pH but without evidence of permeability changes to trypan blue bound proteins. A rapid recovery with complete normalization of cell volume and membrane potential but with limited restoration of intracellular pH took place within 30-60 minutes although the osmolality of the medium remained low. These results strongly suggest that the cerebrovascular endothelium has a built-in high capacity for selfregulation which undoubtfully is important for normal function of BBB.